MtDNA Damage and Apoptosis in Neurodegeneration

Many forms of neurodegeneration are associated with oxidative stress. Although the molecular mechanisms of neurodegeneration remain unknown, it has been proposed that the symptoms associated with several late-onset neurodegenerative diseases are the result of mitochondrial dysfunction and increased production of mitochondrial- generated reactive oxygen species (ROS). Preliminary studies using quantitative polymerase chain reaction show an age-associated increase in basal levels of mouse brain mitochondrial DNA (mrDNA) damage. We hypothesize that oxidative damage to mtDNA leads to a decline in mitochondrial function with concomitant increase in mitochondrial- generated ROS. The hypothesis predicts that impairment of mitochondrial function due to oxidative mtDNA damage can lead to neuronal apoptosis. Increasing evidence implicates apoptosis as a major mechanism of cell death in neurodegeneration is yet not known. This project will explore the molecular mechanisms of neuronal cell death by using the 3-nitropropionic acid (3-NPA) animal model of Huntington's disease. Recent evidence has suggested that 3-NPA, a mitochondrial neurotoxin, can lead to striatal apoptosis and neurodegeneration. is caused by an accumulation of mtDNA damage induced by oxidative stress. To test this hypothesis this application proposes: 1) to examine the association between mtDNA damage and apoptosis in mouse brain exposed to 3-NPA; 3) to examine the association between mitochondrial dysfunction and oxidative stress exposed to 3-NPA; 3) to determine the association between mtDNA damage, ROS production, and apoptosis in mouse striatum exposed to 3-NPA; and 4) to analyze the effect of inhibitors of caspases in mouse striatum on mtDNA damage, generation of mitochondrial ROS, and apoptosis after treatment with 3-NPA. This study will lead to a better understanding of the role of oxidative stress and mitochondria in apoptosis associated with neurodegeneration.